BIOINFORMATICS

BIOINFORMATICS CORE SUMMARY
The Bioinformatics Core serves as a centralized resource for providing expert and timely bioinformatics
consulting, analysis, collaborative research, management, and training solutions for a broad range of
biomedical data including high-throughput data. The Bioinformatics Core will support the specific aims of the
INBRE IV: Hawaii Statewide Research & Education Partnership (HiSREP) by providing a strong and integrated
bioinformatics service in research, education, investigation and creation of innovative methodologies.
During INBRE III, the Bioinformatics Core was reorganized to better serve as a resource to the HiSREP
community, and consequently made substantial progress. We observed an annual increase in the number of
users (nearly 5-fold) utilizing the Bioinformatics Core services from almost all the HiSREP institutions. The
Bioinformatics Core has successfully provided bioinformatics/biostatistics training and education opportunities
to the HiSREP community. During INBRE III, the Bioinformatics infrastructure was also significantly enhanced.
Specifically, an Illumina NextSeq 500 machine was recently purchased and will function to greatly accelerate
the next generation sequencing-based research in the HiSREP network. In addition, a Cray CS300
Supercomputer was installed at UH ITS Center, to which the Bioinformatics Core has full access.
In INBRE IV, the Bioinformatics Core will continue to function as an important component of the network.
Specifically, the Core will contribute to INBRE IV objectives in three key ways: (i) Customized Services: the
core will facilitate the acquisition of preliminary data for grant applications and subsequent research by
HiSREP investigators via consultation on experimental design and data management as well as offer expertise
in data analysis and interpretation in bioinformatics and biostatistics; (ii) Education and Training: the
Bioinformatics Core will provide education in bioinformatics and biostatistics, as well as support for the career
development of researchers (both students and faculty), and; (iii) Core Development: the Bioinformatics Core
will create new tools and methods or repurpose existing tools and strategies to accelerate advances in the
science. In all of these activities, the Core will work collaboratively with other local and national bioinformatics
cores.
To reach these goals, we propose four Specific Aims: (1)
Expand Bioinformatics Core services to
support
biomedical research needs of HiSREP investigators
in the performance of their research. (2) Provide
education and training opportunities in bioinformatics-related topics to all stage HiSREP research students and
scientists as well as community partners. (3) Develop novel bioinformatics tools to enhance bioinformatics
research through the interactions of the combined and expanded expertise of the Bioinformatics Core. (4) Build
institutional and community research synergy through the interaction and collaboration with the HiSREP
partners.